New Mechanisms of and Mouse Models for Medulloblastoma

DESCRIPTION (provided by applicant): Medulloblastoma, a common form of primitive neuroectodermal tumor (PNET), is among the most malignant of the pediatric brain tumors with an average 5-year survival rate of only 50%. Medulloblastoma is believed to arise from the undifferentiated external granule layer (EGL) cells in the cerebellum but the mechanism remains unknown. Our preliminary results suggested a novel mechanism for the development of medulloblastoma. We found that medulloblastoma cell lines overexpress a transcriptional repressor, RE1-Silencing Transcription Factor (REST)/Neuron Restrictive Silencer Factor (NRSF), that countering the actions of REST/NRSF inhibits the cells' tumorigenic potential in nude mice, and that 50% of human medulloblastoma tumor specimens overexpress REST/NRSF. Our more recent experiments indicated that when neuronal stem cells (NSCs), which do not normally express REST/NRSF, are engineered to overexpress REST/NRSF, they form intracranial PNET-like tumors in nude mice. Thus, our working hypothesis is that overexpression of REST/NRSF in NSCs cause medulloblastoma in vivo. In this grant, the following 3 Specific Aims are proposed. First, our hypothesis will be tested by, using the reporter gene-tagged NSC line, C17.2, which resemble EGL cells and can be traced after intracranial implantation. REST/NRSF and another reporter gene (GFP) will be stably and inducibly coexpressed in C17.2 cells and their intracranial tumorigenic potential will be examined in newborn, young, and adult mice. The role of the two repressor domains of REST/NRSF in this process will also be determined. Because of the GFP expression, this orthotopic mouse model will also be a noninvasive system for studying tumor properties by optical imaging. Second, transgenic mice expressing inducible levels of REST/NRSF will be constructed to determine whether the hypothesis is correct under physiological conditions. Third, as REST/NRSF controls transcription by modulating chromatin, a recently developed novel chromatin reconstitution system will be used to identify these interactions and examine their roles in medulloblastoma formation. Thus, by combining developmental biology, transcription biology, and cancer biology, the proposed studies will yield critical information towards our long-term goal of studying the genesis of medulloblastoma and produce mechanism-based animal models that can be used to identify new, physiologically relevant targets for therapy and to test both existing and new drugs for medulloblastoma.